Gene regulatory and metabolic network structure, function and evolution

PROJECT SUMMARY
Metabolism and gene expression lie at the heart of most, if not all, biological processes and both
can go awry in a plethora of human diseases. Metabolic changes affect gene expression and vice
versa. While the interplay between metabolism and gene expression has been studied at the level
of individual genes and pathways, many questions remain unexplored, especially at the systems,
or network, level. The central question underlying this proposal is: How, where and why does
transcription control metabolism and vice versa? Several key questions and challenges pertaining
to this overarching question will be addressed using the nematode C. elegans as a whole animal
model system. We will employ genetic screens, gene expression profiling and metabolomics to
answer key questions at different levels of resolution: from the network level, to the pathway level,
the circuitry/molecular level. This enables us gain both broad, systems-level as well as deep
mechanistic insights into the metabolic control of gene expression and the transcriptional control
of metabolism.

Public health relevance
PROJECT NARRATIVE Gene regulation and metabolism are among the most important processes driving health. While each of these processes has been mechanistically studied for individual molecules and pathways, little is known about how they influence each other at a systems level. In this project, we will continue our studies of the interplay between metabolism and gene expression using the nematode C. elegans as a model system.